Core--human studies

(Applicant's Abstract) The primary function of the Human Studies Core is to support individual research projects within the SCOR by providing the personnel, facilities, and structure to accomplish the following specific aims: (1) To generate and maintain an asthma patient database; (2) To provide a central facility using uniform criteria for recruiting and screening patients for clinical studies; (3) To provide a central facility for performing all bronchoscopic and airway challenge procedures; (4) To coordinate the distribution of patient specimens for analysis in individual projects; (5) To provide quality control and proper patient safeguards in the acquisition of patient specimens; and (6) To provide expertise in statistical analysis, study design, and data management.